Short course combination regimens for treatment of Mycobacterium avium pulmonary disease: a translational bench-to-bedside approach

Project Summary
Nontuberculous mycobacteria (NTM) including Mycobacterium avium complex (MAC) are among the most
difficult to treat etiological agents associated with pulmonary disease. Just between 2008-2015, the annual NTM
lung disease incidence increased from 3.13% to 4.73% per 100,000 persons, and the annual prevalence
changed from 6.78% to 11.7%. The current American Thoracic Society guidelines recommend a macrolide-
ethambutol-rifamycin combination therapy for treatment of pulmonary MAC, where therapy continues for 12-
months after converting one’s sputum culture to negative (no growth or microbiological clearance). We performed
a meta-analysis and found that despite an average 18–23-month long therapy duration, the sustained sputum
culture conversion rates at the end of therapy were only 54% with the macrolide containing regimen and 32%
with macrolide-free regimens. Thus, there is need for safe, more effective, and shorter-course regimens for
treatment of MAC pulmonary disease. However, there is a knowledge gap in the
pharmacokinetics/pharmacodynamics-based guidelines on dose and combination regimen composition as well
as information on the synergy/antagonism between the drugs, at the given dose, in the combination. As a result,
the treatment regimen for MAC infections is largely empirical and driven by clinical experience. To fill in the
knowledge gap, we devised a programmatic approach for unbiased screening of the drugs (old, new, and/or
repurposed) for efficacy against MAC to perform dose selection using the principle of
pharmacokinetics/pharmacodynamics. We use a pre-clinical hollow fiber system model of MAC (HFS-MAC) in
tandem with a mouse model of MAC, clinical trial simulations, and time-to-extinction modeling using pre-clinical
and clinical data to design and rank efficacious combinations of drugs for MAC killing and accurate estimates of
therapeutic duration. The safety and toxicity profile of the drugs we propose to advance, in this grant proposal,
for treatment of MAC pulmonary disease is well documented, data on human population pharmacokinetics are
available, and the mechanism of action and the effective tissue penetration are also available for most of the
proposed drugs. Thus, exposure targets for maximal kill, identified in the pre-clinical models can be translated
to a clinical dose to treat patients with MAC pulmonary disease in a relatively shorter timeframe. We aim to
shorten the therapy duration for pulmonary MAC from the current >18 months to <6 months.

Public health relevance
Project Narrative This proposal seeks to define new regimens of drugs at optimal dose combinations to cure pulmonary Mycobacterium avium complex (MAC) infections for which current therapeutic regimens are empirical and clinical trial evidence to guide precision dosing is lacking. When causing the disease, MAC pathogens are inside the cells, thus, we selected the drugs for this proposal based on their ability to penetrate and accumulate inside cells, thereby effectively killing the MAC in relatively less time compared to the current guideline-based combination regimen. Since the safety and toxicity profile of the proposed drugs in humans is well documented, the new short-course regimens could be quickly advanced into clinics for the treatment of MAC pulmonary disease.